BLR&D Research Career Scientist Award Application

PROJECT SUMMARY/ABSTRACT: Dr. Pasinetti is a Senior Research Career Scientist and Director, Basic
and Biomedical Research and Training, Geriatric Research, Education and Clinical Center (GRECC) at the
James J. Peters Veterans Affairs Medical Center (JJPVAMC). He is also the Saunders Family Chair of
Neurology and an Endowed Professor in the Departments of Neurology, Psychiatry, Neuroscience, and
Geriatrics and Adult Development at the Icahn School of Medicine at Mount Sinai's Brain Institute and the
Director of the National Institutes of Health (NIH) funded Center for Molecular Integrative Neuroresilience.
He has continued to successfully forge new collaborations with Veterans Affairs (VA) and non-VA clinician
scientists, both locally and nationally, since my RCS renewal in 2016. Significant progress has been made in
his research endeavors, reflected by 111 peer-reviewed manuscripts of his over 300 coming in the last
10 years (2013-2023) in high impact journals (H-index: 84; citations > 22,700 according to Google
Scholar) and strong grant support from VA, NIH, Department of Defense (DoD), and other organizations. In the
last decade, Dr. Pasinetti has continued this line of research to further understand the biological mechanisms
related to the aging process and how exposure to environmental toxins and psychological stress can exacerbate
and accelerate the pathogenesis of neuropsychiatric and neurodegenerative disorders. The overall goal of Dr.
Pasinetti's research is to identify therapeutic targets and develop novel preventative and therapeutic approaches
for neurological disorders with neuropathological features of neuropsychiatric disorders such as depression,
anxiety, and the complex Gulf War Illness (GWI), while accounting for their risk factors in the pathogenesis of
Alzheimer's disease and related dementias. With the support from several VA, DoD, and NIH grants, he has
focused on the development and characterization of certain “natural drugs”, as well as clarifying the role of the
gut microbiome at the genomic level in the promotion of cognitive and psychological resilience against stressful
events. Dr. Pasinetti's BX004583 Merit Review Award study aimed to elucidate the role of microglia in the onset
and progression of GWI and could provide significant evidence to test therapeutic approaches that causally
inhibit microglia activity to both prevent and limit progression of the disorder. His DoD study, W81XWH-18-
GWIRP-IIFRA, was designed to address this possibility and to discern whether turning off pro-inflammatory
microglia in a mouse model that recapitulates exposure to GWI neurotoxins and psychological stress can prevent
the onset of GWI-like symptoms. Building on evidence from BX004583 preclinical studies and infrastructure
established through the P50 AT008661 and U19 AT010835 NIH Center grants, he conducted a Phase I trial
through the support of the DoD W81XWH-14-1-0599 to explore dose compliance, safety, tolerability, and
pharmacokinetics of a Flavonoid-Rich Preparation to treat cognitive deficits and chronic fatigue in Veterans with
GWI, with findings clearly supporting safety and tolerability of concord grape juice at certain dosages. Dr.
Pasinetti's U19 AT010835 Center grant consists of validation studies of bioactive polyphenolic compounds
to provide insights about molecular mechanisms associated with resilience against innate immune
responses in the brain. This study will provide direction for translational studies aimed to conduct
pharmacokinetics and steady-state profile of polyphenol metabolites with inflammatory markers of
biological resilience in response to stress models tested in humans. Leveraging on his decennial experience
and funding in neuropsychiatric and neurodegenerative disorders, and the growing evidence of immune-
inflammatory responses in certain forms of dementia, he recently obtained a new VA Merit Award BX005907
funding to further characterize the neuronal-pro-inflammatory microglial crosstalk mechanism observed in a
mouse model of ALS/FTD in vivo.

Public health relevance
Project Narrative My current research is focused on understanding molecular mechanisms and pathophysiology that may be at the basis of stress-induced mood disorders, including depression, anxiety, and other neuropsychiatric disorders, and their influence on cognitive dysfunction and neurodegenerative disorders. These studies are investigating the role of psychological stress and toxin exposures in influencing novel neuro-inflammatory mechanisms driving immune-brain interactions to test causal hypotheses regarding neurovascular damage and the active recruitment of peripheral immune signals related to neuropathology and mood-related brain structures which control depression-like behavior, cognitive functioning, and neurodegeneration. The outcomes aim to further characterize and develop targeted therapeutics for conditions that severely impact the veteran population.